Hepatic SLC25a25 in Steatotic Liver Disease Progression

ABSTRACT
The prevalence of metabolic dysfunction-associated steatotic liver disease (MASLD) is rapidly increasing and
impacts 25% of the global population. Metabolic dysfunction-associated steatohepatitis (MASH) is the fastest
growing cause of cirrhosis and liver cancers, but there are no approved targeted therapies for MASH to date.
Thus, there is a critical need to investigate the mechanistic regulators of MASH to develop effective treatments.
Mitochondria are the primary organelles involved in hepatic substrate oxidation and energy production. Declines
in hepatic mitochondrial respiratory capacity occur in parallel with MASH progression, making mitochondrial
regulators potential treatments for MASH. Nuclear-encoded mitochondrial protein SLC25a25 transports ATP and
inorganic phosphate, thus regulating metabolic potential. SLC25a25 is a critical regulator of ATP availability,
which directly impacts rates of mitochondrial oxidation through alteration of the adenylate pool. The goal of this
proposal is to examine the role and regulation of SLC25a25 in the onset and progression of MASH. The
overarching hypothesis is that SLC25a25 is activated in MASLD to restrict hepatic lipid deposition and
progression to MASH via increased mitochondrial fatty acid oxidation. In Aim 1, I will perform the first cross-
sectional analysis of SLC25a25 expression in human samples from patients with obesity across the MASLD
spectrum. In Aim 2, I will employ a hepatocyte-specific loss-of-function model in mice to mechanistically dissect
the role of SLC25a25 in the onset and progression of MASH. This project will reveal the role of SLC25a25 on
MASH development through regulations of hepatic mitochondrial function and metabolic potential. Determination
of the mechanism of SLC25a25 on hepatic mitochondrial function will provide further understanding of the role
of mitochondrial transporters on metabolic function and disease development, paving the way for the
development of new treatments for MASH. The experimental approach harnesses innovative transgenic and
molecular approaches supported by physiologically relevant first-in-human evidence of SLC25a25 expression to
obtain meaningful data on MASH progression. The findings of this proposal have the potential to provide the
conceptual framework for the development of targeted pharmacotherapies for MASH, which can impact clinical
care and outcomes for patients with liver disease.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction-associated steatotic liver disease (MASLD) is a rapidly growing epidemic with no FDA approved treatments and is a significant global health and economic burden. Mitochondria play an essential role in restricting progression of steatotic liver disease to steatohepatitis (MASH) by acting as a relief valve for excess lipid. In this proposal, I will identify the role and regulation of SLC25a25, a mitochondrial solute carrier, in the onset and progression of MASH with the goal of identifying a novel therapeutic target.